Evaluating EHR-based Prediction of Obesity using WHO Weight Velocity Standards and Peak BMI

ABSTRACT
Obesity is a common, pervasive, chronic disease often beginning in early childhood. Although infant growth
characteristics are key signals of lifelong chronic disease risk, there are no current guidelines about how
best to screen for infant growth patterns associated with future obesity risk. Several growth metrics have
been used in research settings to evaluate patterns of infant growth using attained weight or BMI z-scores,
changes in attained weight-for-age (WFA) z-scores, and modeled trajectories of weight or body mass index
(BMI). However, each of these metrics suffers from imprecision or difficulty being implemented in pediatric
clinical practice. In particular, the frequently-used metric of change in WFA >+0.67 z-score units, dubbed “rapid
infant weight gain”, makes incorrect assumptions about infant weight gain, is inconsistently defined, and is
often misinterpreted. In 2009, the WHO published globally-representative infant weight velocity (WtVel)
standard distributions of normal physiological growth by sex, age (monthly to 24 months), and the specific time
interval between measurements (1, 2, 3, 4 or 6 months). These WtVel standard distributions account for
changes in expected growth rates as infants age yet are rarely used in either clinical practice or research,
largely because they are impractical to apply (e.g., 194 different reference charts, one for each combination of
interval length, sex, and age). Inappropriate or poorly-specified infant growth metrics or misinterpretation of
metrics by clinicians threaten our ability to identify infants at risk of developing early-onset obesity. Thus, we
have an urgent need to rethink how infant growth is assessed and interpreted both in clinical practice
and in research settings. With the advancement in computational capacity in electronic health records (EHR)
systems, it is now necessary to examine the clinical performance of more complex research-based infant
growth velocity metrics. The present study aims to assess the feasibility and predictive validity of various
metrics of infant growth velocity among 1.8 million children from a large national clinical EHR dataset. In Aim 1,
we will compare the practical application and demographic inclusivity of 1) WHO WtVel z-scores, 2)
modifications to these WHO methods (WtVel-M), 3) infant peak weight velocity (PWV), 4) infant peak BMI, and
5) change in WFA z-scores using individual longitudinal clinical data. In Aim 2, we will test the ability of each
metric to predict obesity by age 5. We will also externally validate the predictive performance of each metric
using an independent EHR dataset. By the completion of this study, we expect to have rigorously evaluated
both existing research-based and novel metrics of infant growth, characterizing their generalizability and
validity to predict childhood obesity. Our findings will be a critical step towards evidence-based tailored risk
prediction of childhood obesity in the clinical setting, bridging the gap in evidence between research-based
growth standards and clinical practice.

Public health relevance
PROJECT NARRATIVE Infant growth patterns are associated with childhood obesity risk and related chronic comorbidities, but there are currently no clinical guidelines for assessing and interpreting infant growth within the first 2 years of life. Many infant growth metrics identified through research studies lack precision, are often misinterpreted by clinicians, or are difficult to implement in clinical practice. Using large-scale electronic health record data, the proposed study will rigorously evaluate the validity and generalizability of key infant growth metrics, with a focus on the World Health Organization weight velocity standards, to optimize identification of infants at risk of childhood obesity.